Policy and Training Intervention in Responsible Marijuana Sales Practices to Reduce the Risk of Selling to Intoxicated Customers

Title: Policy and Training Intervention in Responsible Marijuana Sales Practices to Reduce the Risk of Selling
to Intoxicated Customers
Principal Investigators: Dr. Gill Woodall, PhD & Dr. David Buller, PhD
Abstract: The new recreational cannabis markets are contributing to morbidity and mortality due to
cannabis- and polysubstance-impaired driving and other harms by selling a social intoxicant (i.e., cannabis) to
already intoxicated customers. In recreational cannabis markets, deterrence efforts to reduce impaired driving
directed at drivers face challenges and an alternative approach is to decrease access to cannabis by alcohol-
impaired customers. The specific aims of the parent project are to: 1) conduct pseudo-intoxicated patron (PiP)
assessments at state-licensed recreational cannabis stores (n=173) in the greater Portland and Salem
metropolitan areas (i.e., Clackamas, Marion, Multnomah, and Washington Counties) in Year 1; 2) implement a
policy and training (PT) intervention in Year 2 designed to increase compliance with Oregon law prohibiting
sale of recreational cannabis to obviously intoxicated customers with a group of stores (n=65) assigned at
random, that intends to a) make owners/managers of stores aware of Oregon’s law prohibiting sales of
cannabis to obviously intoxicated customers, b) increase their risk perception and motivation to comply, and c)
train store personnel in skills to recognize signs of intoxication and refuse sales; 3) compare PT intervention
stores to usual and customary policy and training (UC-PT) stores (n=108) in a randomized controlled trial by
posttesting recreational cannabis stores in greater Portland and Salem with PiP assessments in Year 3; and 4)
estimate impact of the PT intervention on refusal to PiPs by implementing the PT intervention with the
remaining stores in Portland and Salem in Year 4 in a partial cross-over design and assessing state-licensed
stores in greater Portland and Salem with the PiP protocol. Also, a sample of 39 alcohol premises were assessed
that are co-located near the recreational cannabis premises to explore local area neighborhood effects on
compliance with restrictions to sell to intoxicated customers. These analyses will determine if neighborhood
effects are detected in concordance in compliance in alcohol premises and cannabis stores. The aim of this
administrative supplement proposal is to add alcohol premises (n=50) to the parent project sample increasing
the sample to n=89 alcohol premises to improve representativeness of the sample and increase statistical
power and precision in the geospatial analyses examining neighborhood effects on compliance. The parent
project research is innovative and high impact by testing one of the first interventions to prevent recreational
cannabis sales to obviously intoxicated customers in one of the first states to ban such sales. It can be a model
intervention for the 24 states that have legalized recreational cannabis. The planned geospatial analyses are
innovative, being the first examination of neighborhood area effects on compliance with responsible sale
regulations in both recreational cannabis and alcohol sales to intoxicated customers. Findings will inform
regulators’ actions and have implications for policy, training, and enforcement to improve policy effectiveness
in alcohol and recreational cannabis markets.

Public health relevance
The new recreational cannabis markets are contributing to polysubstance-impaired driving and other harms, especially when cannabis is used in combination with alcohol, by selling cannabis to obviously-intoxicated customers. Compliance with bans on sales to intoxicated customers in the cannabis market may be related to compliance in the alcohol market with this same type of ban, due to local community influences. In the research supported by an administrative supplement, the concordance in compliance with bans on selling to obviously intoxicated customers by alcohol and cannabis establishments will be estimated and examined for effects of neighborhood characteristics.